SPECT IMAGING OF DOPAMINE FUNCTION IN BIPOLAR DISORDER

The study of amphetamine (AMPH) induced dopamine (DA) release in bipolar disorder will explore abnormalities in presynaptic dopamine release mechanisms as well as study post-synaptic DA receptors.The general aim of this study is to evaluate potential neurochemical correlates of AMPH challenge in patients with bipolar disorder currently stable on the mood stabilizer--lithium. Patients with bipolar disorder and healthy controls matched for age, sex and ethnic origin will undergo one SPECT experiment with the D2 tracer [123I]IBZM.